Caribbean Research Ethics Education Initiative (CREEi)

Program Director/Principal Investigator (Last, First, Middle): Philpott-Jones, Sean
PROJECT SUMMARY
Clarkson University, in partnership with St. George's University (SGU) in Grenada and the Universidad
Autónoma de Querétaro (UAQ) in Mexico, currently offers a National Institutes of Health (NIH) Fogarty
International Center (FIC)-supported graduate level online/onsite certificate program to build research ethics
capacity in the independent low- and middle-income countries that border the Caribbean Sea. That program,
the Caribbean Research Ethics Education Initiative (CREEi) is now in its fifth year. By the end of the current
funding cycle this program will have graduated 72 trainees from 17 countries: Antigua and Barbuda, Belize,
Columbia, Costa Rica, Cuba, the Dominican Republic, Grenada, Guatemala, Guyana, Honduras, Jamaica,
Mexico, Panamá, St. Lucia, St. Vincent and the Grenadines, Suriname, and Trinidad and Tobago. An addition
8 trainees will complete the program by June 2019. Additionally, 17 alumni have or continue to receive
additional training and education in research ethics (a Master’s of Science in Bioethics [Research Ethics])
through the Bioethics Program of Clarkson University and the Icahn School of Medicine at Mount Sinai.
Program and alumni accomplishments of note include: establishing the first bioethics center in Mexico (the
Unidad de Bioética at UAQ); serving on national and international ethics commissions; taking policy positions
in several government ministries and regional organizations; publishing numerous peer-reviewed papers,
chapters and books on research ethics; obtaining external funding for ethics-related projects; organizing and
hosting conferences and workshops on research ethics; and developing and teaching new onsite and online
courses on research ethics and scientific integrity at degree-granting institutions throughout the Caribbean.
The Clarkson-SGU-UAQ partnership is applying for a five-year extension to educated an additional 45
trainees, develop new two-year twelve-course Master’s in Bioethics programs at SGU and UAQ, to support the
network of 72 alumni and 8 trainees in their efforts to develop and strengthen research ethics infrastructure at
home, to provide additional training and capacity building activities to local stakeholders through a series of
intensive onsite workshops, to support the Unidad de Bioética as a center of excellence in Mexico, and to
establish the new Center for Global Bioethics as a center of excellence in Grenada. Select trainees and alumni
will also have opportunities to: 1) serve as mentors for future trainees; 2) accept positions as faculty in the
CREEi program; and 3) apply for small in-country research and training grants. The current program will also
be changed to: 1) revise and update the curriculum in response to internal and external reviews, and to create
free-standing Master’s programs at SGU and UAQ; 2) create a single bilingual training program using
simultaneous translation for all courses in order to promote cross-cultural and trans-linguistic learning and new
opportunities for collaboration in the region; and 3) provide additional training in policy and pedagogy so that
trainees are better equipped to be research ethicists and educators, advocates for human research and animal
subject protection, and institutional and national leaders in their home countries.
OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Philpott-Jones, Sean PROJECT NARRATIVE The rapid growth in the number of clinical trials and other research studies being conducted in the low- and middle-income countries (LMICs) that border the Caribbean Basin illustrates the urgent need to develop research ethics capacity and infrastructure in that region. Falling to do so puts the over 270 million residents of the region at risk; their safety and rights as research subjects are likely to compromised unless there is a robust system of regulatory review and oversight. In this proposal, Clarkson University (US), St. George’s University (Grenada) and the Universidad Autónoma de Querétaro (Mexico) outline a plan that will continue their long-standing collaboration, which has already provided graduate-level education in research ethics to 72 trainees from the region, and allow them to: 1) develop a new Master’s program in research ethics; 2) educate an additional 45 trainees from across the Caribbean; and 3) provide additional research and educational opportunities in ethics that will allow program alumni to function independently or collectively as researchers, educators, and policy advocates. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page